Community Engagement Core

Abstract:
A growing concern among practitioners of Community Based Participatory Researcher
(CBPR) is the lack of clarity and effort given to dissemination efforts. While CBPR has
excelled at partnering with communities in developing and conducting research, we still have
steps to take in effectively disseminating research findings to partners and local or national
audiences. The Community Engagement and Dissemination Core (CEDC) will complement
the work of the Investigator Development Core (IDC) by assisting with and modeling
innovative community engaged methods of dissemination to diverse stakeholder groups. Our
specific aims are to serve as a hub for HDR@UCR community engaged dissemination
activities, and build and strengthen a shared community focus on health disparities and
equity. We will achieve these specific aims through a combination of intensive training,
technical support, and equal partnerships with our stakeholders. Our dissemination activities
will be collaboratively developed with community partners and thus be meaningful to
stakeholders at multiple levels who are impacted by research findings that reflect their real
world concerns and encounters with health systems and policies.
1